Enhancing UNderGraduate Education and Research in AGing to Eliminate Health Disparities (ENGAGED)

The Enhancing UNderGraduate Education and Research in AGing to Eliminate Health Disparities (ENGAGED)
program will address the clear need to increase the diversity of biomedical scientists involved in aging research
and the dearth of under-represented (UR) trainees in graduate programs in the biomedical sciences,
particularly in aging-related fields. Given the strengths in research on aging at Wake Forest School of
Medicine (WFSM) and in the existing didactic training in gerontology and aging-related topics at Wake Forest
University (WFU) and Winston-Salem State University (WSSU), the ENGAGED Program Faculty (including
Program Directors at WFSM, Co-Directors at WFU and WSSU) has vast academic and professional
experiences; a history of collaborations for diversity-focused research and training programs; basic, clinical,
population and translational research expertise and funding; and training program administration expertise.
Thus, we are particularly well-positioned to offer training for undergraduate UR students to promote greater
interest, exposure, and research experiences in the science of aging and health disparities in aging. The goals
are to (1) increase awareness of the unique health care issues facing a diverse aging population and of the
opportunities for research that addresses these issues and (2) expand opportunities for hands-on paid
research internships at WFSM, WFU and WSSU during the academic year and during an 8-9 week summer
session. These goals will be accomplished by ‘gerontologizing’ freshman seminars and introductory health
science courses with lectures on topics relevant to aging; creating an ‘ENGAGED Research Club’ to foster a
sense of community around the science of aging; providing a variety of educational activities, including field
trips to research laboratories and geriatric clinics, real-world learning experiences in geriatric assessments and
laboratory procedures, relevant workshops, seminars and journal clubs; and tracking trainee and program
outcomes. Research internships will be offered under the direction of a diverse group of Research Mentors
with expertise in cancer, cardiovascular disease, diabetes/obesity, kidney function/disease, neuroscience, and
physical function, offering trainees a wide variety of research opportunities in the field of aging. A network of
Research and Career Mentors will provide formal and informal resources and counseling on career paths in
age-related biomedical research, particularly PhD/advanced degrees, during and after the program. Of
note, ~40% of training faculty are UR minorities, and many have research expertise and/or clinical experience
addressing health disparities in aging populations. In sum, the proposed ENGAGED program offers several
innovative approaches to preparing UR students for a career in research in the field of aging and takes
advantage of unique strengths, existing infrastructure, and long-standing collaborations among diverse faculty
at WFSM, WFU, and WSSU to ensure successful creation and implementation of the program. Sustainability
past NIA funding is anticipated once courses are established and successful outcomes for trainees are evident.

Public health relevance
PROJECT NARRATIVE The ENGAGED program takes advantage of the broad, multidisciplinary research established in the area of aging at Wake Forest School of Medicine and our partner institutions, Wake Forest University and Winston- Salem State University. ENGAGED will provide undergraduate students who are under-represented (UR) in the biomedical sciences an opportunity to participate in educational and research training in the field of gerontology/geriatrics, with the goal of advancing diversity in aging research and health disparities research in aging by creating a pipeline for well-trained UR students interested in biomedical, behavioral, and clinical research careers.